Emory Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: DATA MANAGEMENT AND STATISTICS CORE
The Data Management and Statistical (DMS) Core of the Emory Goizueta Alzheimer’s Disease Research
Center (ADRC) supports studies on the causes, progression, and treatment of Alzheimer’s disease and related
disorders (ADRD). The DMS Core accomplishes these goals by merging the data collection efforts of the
Administrative, Clinical, Education, and Neuropathology Cores into a common repository, monitoring the
integrity of these data, and transmitting the information in a timely fashion to investigators at the local, national,
and international levels and to the National Alzheimer’s Coordinating Center. The DMS Core also lends their
expertise on research design and analytic approaches to investigators, collaborates on and initiates ADRC-
related studies, and develops innovative statistical approaches and methodologies. During the current funding
period, the Emory DMS Core has invested heavily in its infrastructure to create an integrated, dynamic and
accessible data solution, including deployment of web-based systems to improve data tracking, integration,
and resource sharing. The DMS Core has engaged in increased collaborations on grants and peer-reviewed
publications, and has developed new innovative methods to integrate multi-omics data and quantify
postmortem tissue.
In the next funding cycle, the DMS Core will achieve the following aims: (1) To continue to maintain a
scientifically rigorous research database that supports NACC, the ADRC Cores, developmental projects, local
investigator-initiated studies, Research Education Component trainees, and national collaborative studies; (2)
To provide statistical consulting and collaboration on the design, conduct, analysis and interpretation of ADRC
related studies and grants; and (3) To develop innovative methods to support biomarker research on AD and
ADRD, with a special emphasis on methods for multi-modal integration of genetics, proteomics, imaging,
together with the clinical data. Through these efforts, leveraging and enhancing data infrastructure created
over the last funding period, and integrating the diverse expertise of Core investigators, the DMS Core will
facilitate cutting edge research to advance the field of AD and ADRD.

Public health relevance
Per RFA-AG-20-004 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.